Combinatorial Approaches to Improved Blood-contacting Polymer Biomaterials

Project Summary/Abstract
Thrombosis and infection remain significant barriers to development and implementation of advanced blood-
contacting medical devices. The objective of this application is to create and test novel biomaterials that
combine chemical and surface texturing approaches to improve hemocompatibility. We will develop novel,
Nitric Oxide (NO)-releasing polymer (PU) materials with topographies ranging in scale from 10’s of microns to
100’s of nanometers and will test these in a rabbit-catheter model and in advanced benchtop testing. The
Central Hypothesis of the work states that
Platelet adhesion/activation and bacterial adhesion are influenced by both surface chemical and
surface physical properties. Biomaterial surfaces bearing a combination of topographic
modification, polymer chemistry and active molecule release that impart resistance to platelet
and bacterial adhesion will increase the efficacy of these materials in reducing platelet
adhesion/activation and bacterial adhesion/biofilm formation beyond what would be expected
from a single modification strategy under both in vitro and in vivo conditions.
To test this hypothesis, we propose 3 specific aims that involve testing catheters in a rabbit model for periods
of 7 and 28 days. These catheters will be based on our published studies showing benchtop success in
reducing platelet and bacterial adhesion by implementation of sub-micron texturing with NO release. In Aim 2,
we will develop more advanced texturing protocols that incorporate feature sizes ranging from 10’s of microns
to 100’s of nanometers simultaneously, and will also incorporate NO release. We will also develop a novel
material based on polyphosphazene chemistry that has shown promising results in benchtop testing but needs
improvement to be suitable for texturing and NO release in a catheter configuration. Finally, we will carry out
basic science studies on these materials in order to identify characteristics that make the materials likely to
succeed in a catheter model as well as to inform the Biomaterials Community about processes involved in
platelet adhesion, biofilm formation and blood coagulation in general. The successful completion of this
application will provide a novel approach to improve the biocompatibility of current biomaterials, improve
patient care and incur cost savings.

Public health relevance
Project Narrative Biomaterial induced thrombosis and infection cause serious problems in blood-contacting medical devices. This project proposes a new strategy of surface modification through combinations of chemical and physical approaches to increase the efficiency in controlling platelet adhesion and activation, bacterial adhesion and biofilm formation, as well as blood coagulation as a method reduce thrombosis and infection on medical devices. The application focuses on animal testing of modified materials, development of improved surface texturing on different polmer materials, and the study of biological responses to combined surface modification.